Connect and Cancer Prevention Cohort Study

The Connect for Cancer Prevention Cohort Study is a new prospective cohort of 200,000 male and female adults in the United States designed to further investigate the etiology of cancer and its outcomes, which may inform new approaches in precision medicine prevention and early detection.